Food Insecurity and Family-based Treatment for Pediatric Obesity

Project Summary/Abstract
Pediatric obesity puts children at risk for long-term, negative health outcomes including cardiovascular disease,
high blood pressure, and stoke, and disproportionately impacts children from low-income families. Low-income
families are also at increased risk for food insecurity. Consistent with the “scarcity mindset” theory of poverty,
food insecurity is associated with increased discounting of delayed rewards and increased present bias. It is
also associated with increased food reinforcement, and decreased likelihood of meal planning. These factors
are in turn associated with increased risk for obesity. Despite the seriousness of this issue, little research has
examined the role food insecurity and its psychological correlates play in behavioral treatments for pediatric
obesity. Family-based treatment (FBT) for pediatric obesity is an effective treatment for childhood obesity that
targets parent-child dyads and achieves long-lasting weight change in children through behavior change
techniques such as reinforcement, stimulus control, preplanning, and parenting skills. However, low-income
households have shown reduced treatment response in similar behavioral obesity treatments and are at
elevated risk for treatment drop-out. The proposed study will examine food insecurity in 208 parent-child dyads
enrolled in a CDC-funded pilot study seeking to adapt FBT for low-income families that will include a unique
emphasis on budgeting and meal planning, which has been shown to predict greater weight loss in previous
studies of obesity treatment, as well as a referral system to link families with social determinants of health
(SDOH) needs, such as food insecurity, to resources. The proposed study will 1) characterize parents with and
without food insecurity using baseline data based on weight and health status, demographics (SES, race,
ethnicity), other social determinants of health needs (e.g. housing, utilities, transportation), scarcity mindset
(delay discounting, relative reinforcing efficacy of food, financial planning horizon, perceived probability of living
to age 75), family nutrition and physical activity, and meal planning behavior; 2) determine the degree to which
food insecurity and scarcity mindset (in parents) moderate weight change after 3 and 6 months of treatment for
parents and children enrolled in FBT; and 3) determine whether increased meal planning and SDOH service
receipt moderate the relationship between food insecurity and/or scarcity mindset, and weight change. By
characterizing the association between food insecurity and weight outcomes in FBT, this study will help guide
the adaptation of FBT for low-income families and improve treatment for a subset of children at
disproportionate risk for obesity.

Public health relevance
Project Narrative Low-income children are at disproportionate risk for both obesity and food insecurity, and research suggests that food insecurity may contribute to obesity risk through factors such as increased discounting of delayed rewards, increased present bias, increased food reinforcement, and decreased likelihood of meal planning. Despite these associations, little research has examined the role of food insecurity and its psychological correlates in the context of behavioral treatment for pediatric obesity. In a sample of low-income parent-child dyads enrolled in family-based treatment (FBT) for pediatric obesity, the proposed study will 1) characterize parents with and without food insecurity on several demographic and psychosocial factors; 2) determine the degree to which food insecurity (in parents) moderates weight change at 3 and 6 months for parents and children; and 3) determine whether meal planning and receipt of social services moderate the relationship between food insecurity and weight change with implications for the adaptation of FBT for low-income families.